A Preclinical Program for Targeting Mycobacterium tuberculosis KasA

ABSTRACT
We present herein a grant application focused on the late-stage development of
preclinical candidate JSF-3285. Per our recently published research, we have disclosed
the genesis of this program that led to the hit compound DG167 and identification of the
essential β-keto acyl synthase KasA as its target. Building on this effort, our preliminary
data detail the optimization to arrive at JSF-3285 which is efficacious in the acute and
chronic models of M. tuberculosis infection in mice at doses as low as 5 mg/kg once-daily
oral. This proposal seeks to build on this data by conducting the requisite drug
combination and relapse studies to achieve clinical status and begin IND-enabling
studies. In addition, we propose a second generation program based on preliminary data
consisting of a structurally distinct amide series with promising in vitro efficacy, mouse
PK, and X-ray structural data. The grant's second aim will evolve this series, leveraging
our extensive X-ray structural data, SAR, and machine learning models, to produce at
minimum novel early lead compounds if not compounds equal to or surpassing JSF-3285.
The sum total of the two aims, featuring JSF-3285 and second generation candidate/s,
will lend a high probability to a KasA inhibitor becoming clinically relevant in the next 5
years.

Public health relevance
PUBLIC HEALTH BENEFIT This proposal will develop a new therapy that will help to cure drug-susceptible and drug-resistant forms of tuberculosis. It will also have the potential to reduce the length of time need to treat tuberculosis and inhibit new resistance from occurring. If our research goals are achieved, the novel therapy would be an important step towards the global eradication of tuberculosis.